High efficient AAV-transducible transgenic quails

Project Summary / Abstract
The main goal of this research proposal is to generate a transgenic quail line that ubiquitously expresses the
human receptor for adeno-associated virus (AAV). Quails and chickens cannot be eﬃciently transduced with
AAV, which precludes the use of this class of popular viruses in these animals. Expressing the AAV receptor
in avian cells, however, signiﬁcantly increases the transduction eﬃcacy for AAV. The ﬁrst aim of the proposed
research is to generate a transgenic quail line that can be tested for eﬃcient virus transduction of the inner
ear in vivo, which is the goal of aim two of the proposal. The ﬁnal aim is to demonstrate that the newly
generated transgenic AAV receptor-expressing quail line can be used for AAV-mediated CRISPR-Cas9
genome editing in the inner ear. The successful completion of this research project will provide a new animal
model for studying avian hair cell regeneration through gene manipulation in vivo. Inner ear sensory hair cells
do not naturally regenerate in mammals but they do in birds, which emphasizes the importance of conducting
genetic manipulations in birds. Knowledge gained with this new experimental model system, such as the
signiﬁcance of speciﬁc signaling pathways and key genes during avian hair cell regeneration, shall be
translatable to mammals, and ultimately can provide insight into curative treatments for sensorineural hearing
loss.

Public health relevance
Project Narrative While birds have the remarkable ability to naturally regenerate vestibular and cochlear sensory hair cells, the systematic testing of candidate genes that mediate hair cell regeneration, however, is hampered by the lack of eﬃcient genetic tools to manipulate avian genes in vivo. This exploratory/developmental research project proposes to generate a transgenic quail line that ubiquitously expresses the human receptor gene for AAV, which will enable the use of AAV-based CRISPR-Cas9 technology in avian inner ear regeneration research. It is proposed to generate the transgenic quail line, to test its suitability for AAV-based CRISPR-Cas9 manipulations, and to make the animals available to the general research community.